Hypothalamic prodynorphin neurocircuits integrating defensive behaviors

Project Summary
Anxiety disorders, such as posttraumatic stress disorder (PTSD), pose a major public health challenge and
currently affect millions of people in the United States. Studies have shown that these diseases are linked to
the persistence of excessive defensive responses, often resulting from impairments in the ability of the brain's
pre-programmed defensive networks to flexibly switch between proper defensive modes (i.e., active fight-or-
flight versus passive freezing). Although significant progress has been made in elucidating the brain structures
that regulate defensive behaviors, the causes of this inflexibility remain poorly understood. Emerging evidence
suggests that neurons in the paraventricular nucleus of the hypothalamus (PVH) are critically implicated in
regulating defensive responses. Approximately half of the PVH neurons express the specific marker
prodynorphin (Pdyn, denoted as PVHPdyn neurons), the precursor of the neuropeptide dynorphin, an
endogenous ligand of kappa-opioid receptors (KORs). In line with the known importance of the
dynorphin/KORs system in regulating diverse physiological processes including stress, anxiety, and feeding,
our preliminary studies have shown that PVHPdyn neurons send abundant parallel projections to the
dorsomedial division of the ventromedial nucleus of the hypothalamus (VMHdm) and the dorsal portion of the
periaqueductal gray (dPAG), the two pivotal brain regions for innate defensive control. We have further
observed that specific activation of the PVHPdyn→VMHdm pathway induces strong flight behaviors in mice,
whereas excitation of the PVHPdyn→dPAG circuit triggers exclusively freezing reactions. In particular, activation
of both pathways suppresses feeding motivation driven by hunger, which is a known survival-promoting
adjustment during defensive states. These findings collectively suggest that PVHPdyn neurons serve as the key
target to regulate flexible defensive responses by integrating both VMHdm and dPAG actions. The proposed
research will test this central hypothesis with three specific aims. Employing an ethologically relevant test
model and a combination of multiple innovative techniques, we will: 1) examine how defensive flight behaviors
are flexibly controlled by the PVHPdyn→VMHdm activity (Aim 1); 2) investigate how defensive freezing
behaviors are dynamically encoded by the PVHPdyn→dPAG activity (Aim 1); and 3) explore how the
coordinated activity dynamics between these two pathways directly orchestrate flexible switches between
defensive modes and contribute to anxiogenic pathophysiology. This research will provide novel insights into
the neural underpinnings governing appropriate defensive responses, opening new avenues for developing
therapeutics that target the hypothalamic Pdyn neurocircuits for treating anxiety disorders associated with
maladaptive defensive states.

Public health relevance
Project narrative The causes of inflexible switching between proper defensive modes, which often results in excessive defensive responses contributing to anxiety disorders, remain poorly understood. In this proposal, we aim to use a multi- faceted approach that integrates ethologically relevant test model, in vivo imaging, and circuit activity manipulations to begin unraveling the role of hypothalamic prodynorphin neurocircuits in regulating defensive behaviors. This study will critically enhance our understanding of the pre-programmed brain mechanisms that control flexible defensive responses.